Development of Population Level Serotyping Technology and Antibody Profiling for Infectious Pathogens with focus on Influenza and SARS-CoV-2

ABSTRACT The goal of this proposal is to repurpose technology developed for Next-Gen Proteomics to develop a highly-scalable digital serotyping technology for infectious disease analysis, with particular application to influenza and Covid-19. The approach is broadly applicable and should greatly improve upon cost, sensitivity, usability, and throughput of population-level serotyping and greatly improve infectious disease monitoring and surveillance.

Public health relevance
NARRATIVE This proposal aims to repurpose and develop technology for user-friendly, high-throughput digital serotyping analysis of infectious pathogens. By enabling serotyping and antibody profiling across large populations, better surveillance and control of infectious pandemics can be achieved.